Impaired myocardial glucose transport during diabetes: the novel role of calcium

DESCRIPTION (provided by applicant): The long-term goals of Veronique A. Lacombe, DVM, PhD are to become an independent, academic investigator, and to conduct cutting-edge translational research in comparative medicine, to better serve the health and welfare of both animals and humans. She is board-certified by the American College of Veterinary Internal Medicine, and received her postdoctoral research training in comparative physiology. This SERCA award will capitalize on her strong dual training in basic and clinical sciences, and is designed to foster her development toward achieving her career goals. An interdisciplinary mentoring team will provide the applicant with an intensive collaborative research experience in the rich intellectual environment of The Ohio State University. The sponsor is Sandor Gyorke, PhD, an internationally renowned leader in cardiac calcium metabolism;and the co-sponsor is Cynthia Carnes, PharmD, PhD, a uniquely qualified translational scientist in cardiovascular diseases. The applicant's research goals are to better understand the pathogenesis of diabetes, and to study interactions between cardiac metabolism and physiologic function. Diabetes has reached epidemic levels and heart failure is the cause of death in 2/3 of diabetic patients. Abnormalities in calcium (Ca) regulation in the myocardium underlie the pathologic contractile changes during cardiomyopathy and heart failure. Furthermore, during diabetes, the mechanisms of abnormal glucose transport in the myocardium are not well understood. In particular, Ca regulation of glucose transport is not well elucidated in insulin-sensitive tissues and is not defined during diabetes. The central hypothesis of this proposal is that altered intracellular Ca homeostasis which develops during diabetic cardiomyopathy, contributes to impaired glucose transport in the diabetic heart. Our aims are to: 1) characterize the impaired cardiac function (in vivo) and Ca homeostasis (in vitro) in the diabetic myocardium;2) to study the effects of in vitro Ca stimulation on glucose transport in normal and diabetic cardiac myocytes;3) to test the hypothesis that treatment with a Ca channel blocker will improve intracellular Ca homeostasis and thus cardiac contractility in the diabetic myocardium;and 4) to test the hypothesis that improved Ca homeostasis (following Ca channel blocker treatment) will increase glucose transport in the diabetic myocardium. This proposal provides a unique and multidisciplinary training opportunity that will allow the candidate to enhance her skills in translational physiology, and acquire additional expertise in electrophysiology, molecular biology, and state-of-the-art in vivo and in vitro imaging techniques. RELEVANCE: Diabetes, a widespread health problem, results in high blood sugar and is known to increase the risk of early heart disease and death. However, there is no real cure. Thus, better understanding of glucose transport in the heart could provide novel insights into heart disease, and new therapies to improve heart function during diabetes.